CE-22-006 The effects of intrinsic foot muscle strengthening interventions on balance, proprioception, and fall risk in adults over age 65

The effects of intrinsic foot muscle strengthening interventions on balance, proprioception, and falls in
adults over age 65
Background: Falls are the leading cause of injury in adults 65 years and older. While causes of falls are
multifactorial, foot function plays a vital role. The intrinsic foot muscles (IFM), those that originate and insert
within the foot, provide stability and sensory input important for balance. Weakness or disuse of the IFM in older
adults can contribute to faulty foot and toe alignment, which have been cited as independent predictors of falls.
Wearing minimally cushioned footwear or performing strengthening exercises that target the IFM may improve
these muscles' strength, endurance, proprioceptive qualities, and foot/toe structure, which may improve
functional mobility and balance in older adults, and thus, prevent falls.
Purpose: The purpose of the proposed research is to analyze the effects of two IFM strengthening interventions
(minimal footwear use or strengthening exercises) on IFM strength, proprioception, foot/toe structure, balance
and functional mobility, and falls incidence in older adults.
Design: Randomized control trial
Methods: Adults ages > 65 years who can ambulate household distances with or without an assistive device
will be invited to participate. Individuals with poor foot sensation, lower extremity amputation, injury or surgery
to the lower extremities or lumbar spine in the previous 6 months, impaired cognitive ability to follow verbal and
written instructions, or vestibular disorders will be excluded. Following informed consent and initial screening,
participants will be randomly allocated to one of four intervention groups (n=120, n=30/group):
1) intrinsic foot muscle strengthening exercises
2) minimal footwear prescribed walking
3) intrinsic foot muscle strengthening exercises and minimal footwear prescribed walking
4) non-minimal footwear prescribed walking (control)
Participants will be encouraged to perform interventions 5 days/week for 16 weeks. After an initial in-person
instruction session, participants will have 1 follow-up meeting to review instructions, after which they will receive
bimonthly phone calls as a reminder to adhere to the intervention and to record any falls and related details.
Participants will be asked to record intervention performance, daily step count (measured by pedometer), and
falls in provided diaries. Balance and functional mobility will be measured using the Mini-BesTest, proprioception
will be measured using the Lower Extremity Position Test, foot and toe structure will be measured using navicular
drop and valgus angle of the 1st metatarsophalangeal joint. Cross sectional area (cm2) of the abductor hallucis,
flexor hallucis brevis, flexor digitorum brevis, and quadratus plantae muscles will be measured using ultrasound
imaging. Measures regarding balance and functional mobility, proprioception, foot/toe structure, and muscle
cross sectional area will occur at baseline, 8, 10, 12, and 16 weeks. Following the 16-week intervention period,
participants will be encouraged to continue their intervention twice per week. Ongoing falls diaries and bimonthly
phone calls from researchers will occur for 12 months after baseline to record long-term fall rate (falls per person
per year).
Data Analysis: a 4 group x 5 time point repeated measures analysis of variance (ANOVA) will be used to assess
changes in balance, and functional mobility, proprioception, foot/toe structure, and muscle cross sectional area.
Falls data will be measured as the rate of falls per person in a 12-month period beginning with the date of the
baseline measure.
Significance: Intrinsic foot muscle strengthening interventions have seldom been studied in older adults and
their effects and mechanism are not established. This will be the first study to assess the effects of these
interventions on proprioception in older adults, the first to use ultrasound imaging measurement following intrinsic
foot muscle strengthening in older adults, and the first study to analyze the long-term effects on falls after the
performance of these interventions. The interventions assessed in this research proposal are simple, safe, and
affordable and may have a major impact on functional mobility and reduction of falls for older adults.

Public health relevance
Narrative Falls are the leading cause of injury in adults over age 65. Muscle weakness in the foot can lead to foot and toe deformities such as collapsed arches or bunions, which have been found to contribute to falls in adults over age 65. The current research study aims to investigate the effectiveness of two simple and affordable foot strengthening methods that may make a major impact on balance and fall prevention in older adults.